Place-based Strengths and Vulnerabilities for Mental Wellness among Rural Minority Seniors

Project Summary
Severe inequities in depression and its diagnosis and treatment among rural-dwelling, racial/ethnic minority
seniors compared to their urban White counterparts result in increased mortality, cognitive impairment, and
multiple co-morbidities, thus presenting a growing public health concern as the United States population ages.
These health inequities are often attributable to social and environmental factors, including economic insecurity,
histories of trauma, chronic gaps in transportation and safety-net services (e.g., food assistance, health care),
and disparities in access to policymaking processes rooted in colonialism that make these groups “structurally
vulnerable” to mental ill health. Fewer data exist on protective factors associated with social and environmental
contexts, such as proximity of social support, community attachment, and a meaningful sense of place. While
the importance of such place-based factors is widely recognized in scholarship on the social determinants of
health, there is to date little research specifically examining how such factors shape disparities in depression
and treatment, as well as limited practical approaches to target these factors and their effects on mental wellbeing
for rural and minority populations. This K99/R00 application proposes to integrate my expertise as a cultural
anthropologist in participatory qualitative research and implementation science with new knowledge in rural
mental health research, quantitative and mixed-method designs, and intervention development, in order to
conceptualize and intervene on the social and environmental causes of mental health disparities. Coursework,
workshops, and the expertise of an interdisciplinary team of mentors at the Pacific Institute for Research and
Evaluation and the University of New Mexico during the K99 period will provide me with the skills to undertake
the proposed R00 research, which will utilize quantitative surveys, qualitative interviews, ecological network
research, and spatial data analysis to elucidate how place-based vulnerabilities and protective factors shape
experiences of depression among rural American Indian and Latinx elders in New Mexico. Guided by Intervention
Mapping, a participatory approach for planning health interventions, data will contribute to a community-driven
plan for a multisystem intervention targeting the place-based causes of disparities in depression, which will form
the basis of a subsequent R01 implementation and evaluation study. This participatory and interdisciplinary study
will elucidate how axes of difference pertaining to place, rurality, and minority status drive mental health
disparities. The resulting place-focused intervention plan will improve mental health equity for aging populations
that data show are severely and persistently underserved and advance the science of intervention and
implementation beyond its predominant focus on individuals and healthcare settings. Data and training will
contribute to my independence as an investigator focused on the social causes of health disparities and translate
directly into future NIH-funded research targeting the upstream causes of mental health disparities in this and
other underserved populations.

Public health relevance
Project Narrative Inequities in depression and its diagnosis and treatment among rural-dwelling minority seniors, which are often rooted in place-based social and environmental factors (e.g., economic insecurity, histories of trauma, and gaps in health and social services), present a major public health burden. This K99/R00 application proposes to integrate my expertise in participatory qualitative research and implementation science with new knowledge in rural mental health research, quantitative and mixed-method designs, and intervention development, in order to enhance my independence as a researcher focused on addressing these social and environmental causes of health disparities, which the National Institute of Minority Health and Health Disparities has identified as a major priority. The proposed R00 research will elucidate how place-based vulnerabilities and protective factors shape experiences of depression among rural American Indian and Latinx elders in New Mexico, and contribute to the development of a plan for a community-driven place-focused intervention to reduce mental health disparities in this and other marginalized populations.